Engineering hydrophilic/amphiphilic Vitamin B6-based super antioxidant dendrimers for controlling chronic inflammation

Project Summary
Funds are requested to purchase a new CEM (Discover-2.0) microwave synthesis reactor, which will be installed in
the Dow Science building (Dow 345) at Central Michigan University (CMU). Microwave reactors can raise temperatures
rapidly by irradiating polar materials in a chemical reaction with microwave energy. In addition to rapid heating, they can
carry out chemical reactions under high pressure, enabling the reactions to be heated beyond the boiling point of the
solvent being used. Therefore, microwave reactions are much faster compared to thermally heated reactions.
Our proposed research is to synthesize and evaluate antioxidant dendrimers formed by joining dendrons with various
solubilities to attain solubilities that are biocompatible. All the dendrons and dendrimers involved in this research are
designed to produce strong antioxidant activity but no pro-oxidant effects by trapping the transition metal ions within their
interior. To attach antioxidant building blocks to a scaffold in our dendron/dendrimer synthesis, we use “alkyne-azide
click chemistry”, which requires a copper catalyst. The use of copper ions as catalysts results in severe contamination of
our dendrimer with copper ions due to the ability of the dendrimer to chelate copper ions. Therefore, we use copper metal
granules instead. Copper metal is a far less efficient catalyst than copper ions, but it does not contaminate our antioxidant
products, which is very important. To accelerate the reaction rates, we utilize a microwave reactor with which we can
form our target products usually in 10-15 hours (> 1 week without).
We have a 14-year-old microwave reactor which fails very frequently due to its deteriorating parts with age. It is
difficult to start, and if it starts it only runs for 2-3 hours at a time. Without a microwave, our current grant-funded
research will be greatly impacted because long synthesis times will hamper other objectives to be achieved within the
proposed time frame. Currently there are no other microwave reactors in the entire CMU community. In summary, (i)
availability of a microwave reactor is extremely important for syntheses of our proposed dendrons and dendrimers, which
are large and complex molecules and (ii) this supplementary funding will allow us to train undergraduate/graduate
research students. We believe that procurement of a state-of-the-art microwave unit with this Administrative Supplement
will help accelerate the pace of our proposed research as well as help students acquire useful modern microwave synthesis
techniques.

Public health relevance
Public Health Relevance Statement (Narrative attachment) We will synthesize safe, powerful and hydrophilic/amphiphilic antioxidant dendrimers that would be beneficial for the prevention and treatment of diseases that have a strong association with oxidative stress (chronic inflammation), such as cancer, diabetes, asthma, atherosclerosis, arthritis, and neurodegenerative diseases. The synthesized hydrophilic/amphiphilic super antioxidants in a dendritic architecture will be tested to investigate their protective effects on biomolecules and anti-inflammatory action on cells against free radicals.